Pediatric Cardiovascular and Pulmonary Research Training Program

PROJECT SUMMARY/ABSTRACT
This is a renewal application for a high successful program designed to attract and train both predoctoral and
postdoctoral investigators in basic investigation of childhood diseases related to cardiovascular and pulmonary
biology. The need for a training program in the cellular and molecular basis of cardiovascular and pulmonary
disease, especially of physician scientists interested in childhood diseases, is based upon clear evidence of a
declining national pool of such individuals at both the faculty and trainee levels. Currently, few pediatric
cardiology or pulmonary fellowship programs in American medical centers provide adequate training in this
area of research, either at the bench or in structured clinical investigation. Our program is designed to address
this need from two important perspectives: 1) To allow pediatric and other clinical fellows with an interest in
basic research to develop research competence and career training; 2) To attract and train talented basic
scientists at the pre- and post-doctoral levels to study mechanisms related to cardiorespiratory disease in
childhood. Our program has been shaped by feedback from reviewers of the previous program, by advice from
our faculty and program advisors, by past trainees, and by the inclusion of new faculty and core programs at
Washington University that allow us to expand the training experience of our trainees. In addition to continuing
our strong training in developmental/cell biology and the molecular basis of disease, the proposed program will
take advantage of institutional strengths in genetics, stem cell biology, genomics, and bioinformatics—all of
which are components of the foundation of modern research. In addition, we have a newly incorporated focus
on infection of the cardiorespiratory system, a leading cause of pediatric morbidity and mortality worldwide. We
have maintained a training curriculum for 4 postdoctoral and 2 predoctoral fellows with an uninterrupted 2-3
year block of full-time investigation. This focus is enhanced by a multidisciplinary core of didactic seminars,
journal clubs and formal coursework that are designed for each trainee through consultation with the
mentor/program administrators to provide individualized education in key aspects of cardiopulmonary
development and disease. Our objectives are: 1) to provide extensive mentoring to the trainee for career
development and for developing independent research plans that focus on pediatric diseases; 2) to promote
training in basic cell and molecular biology, genomics, and bioinformatics together with clinical translational
research; and 3) to guide our trainees’ development so that, after the completion of training, successful
competition for independent funding is likely.

Public health relevance
PROJECT NARRATIVE Congenital and acquired diseases of the heart, vasculature, and lungs remain among the most common causes of death in infancy, children, and young adults. The purpose of this training program is to attract and train young scientists to study fundamental mechanisms that underlie cardiorespiratory disease in childhood.